IMSD@UNTHSC

Project Summary/Abstract
Increasing the entry of underrepresented minority (URM) groups into graduate programs is essential, but
retention will translate into higher numbers of minority groups entering biomedical research careers. Evidence
suggests that providing research-training opportunities is a successful mechanism to increase and sustain a
student’s motivation and skill acquisition to pursue biomedical and behavioral research career paths among
URM populations. For 30 years (1993), The University of North Texas Health Science Center (UNTHSC) has
dedicated its educational mission to train a talented and inclusive workforce evidenced by its long-standing
commitment to providing pathways for training individuals that historically are underrepresented in biomedical
research, behavioral science, and health profession careers. UNTHSC attracts a diverse student body within
Texas, neighboring states, and prides itself on the number of PhDs awarded to students which earned their
bachelor’s degree from minority-serving institutions (e.g., HBCUs, HSIs, PBIs) and low-resource institutions
which enriches its overall diverse demographic across all its schools. UNTHSC’s institutional efforts to promote
diversity and enhance research training is the implementation of its Coordinated Plan to Diversify the
Biomedical Research Workforce. This plan is designed to enhance awareness of educational opportunities
for students in K-12, provide training in academic skills that is focused on biomedical and behavioral science
research for a diverse and inclusive student body by student recruitment from partner institutions and non-
partner institutions and increase financial and economic opportunities for graduate students during both M.S.
and Ph.D. studies. The overarching goal of the IMSD@UNTHSC is to support the timely completion of Ph.D.
degrees by underrepresented groups and their transition into successful biomedical careers. Our objectives
are to 1) Recruit a competitive pool of underrepresented students that complete a Ph.D. and 2) Ensure that at
least 80% of Ph.D. students will complete the Ph.D. degree at or in less time than 5.2 years within the median
of 4.88 to 5.73 years for all biomedical sciences. The expected impact of IMSD@UNTHSC includes a more
holistic training program that is supportive of the timely completion of Ph.D. degrees by underrepresented
groups and their transition into successful biomedical careers.

Public health relevance
Narrative As the Nation becomes increasingly diverse, we must include all individuals, particularly those historically underrepresented in STEM and biomedical sciences if we are to advance biomedicine for our citizenry. The overarching goal of the IMSD@UNTHSC is to support the timely completion of Ph.D. degrees by underrepresented groups and their transition into successful biomedical careers. The project has two main objectives: Objective 1) Recruit a competitive pool of underrepresented students that complete a Ph.D. and continue into biomedical research careers and Objective 2) To ensure that at least 80% of Ph.D. students will complete the Ph.D. degree at or in less time than 5.2 years within the median of 4.88 to 5.73 years for all biomedical sciences.